Computational Approaches to Studying Immunodominance.

DESCRIPTION (provided by applicant): T-cell responses are activated by short peptides derived from foreign proteins of pathogenic origin. Each pathogen consists of thousands of potential immunogenic antigens, but only a small fraction of these epitopes are recognized by CD8 T-cells during the course of an infection. This phenomenon, known as immunodominance, is fundamental property of T cell immunity (Yewdell and Bennink, 1999), and results from many factors that govern antigen presentation and T-cell activation (Yewdell, 2006). The large quantity of available immunological data, such as HLA binding measurements, has led to the development of powerful modeling tools that provide robust estimations of several processes that are part of the adaptive immune pathway, including MHC binding (Peters et al., 2006; Lin et al., 2008), proteasomal cleavage (Kesmir et al., 2002; Schatz et al., 2008), and Transporter Associated with antigen Processing (TAP) (Peters et al., 2003). Recent work has shown the viability of using such prediction tools in epitope mapping studies (Moutaftsi et al., 2006; Assarsson et al., 2008). However, developing computational tools to study immunodominance has not been explored, partially due to the lack of sufficient amounts of data to learn such models. We propose a computational approach for studying immunodominance both in terms of antigenic context and host genetics. We will develop and evaluate new computational tools for studying immunodominance. We will then use these tools to predict immunodominant responses, and to study its underlying mechanisms. The core of our approach involves the ability to predict HLA-peptide interactions, leveraging previously developed tools for this analysis. We demonstrate initial results that compare in vitro and in silico epitope mapping on a set of matched cases and controls from the Step HIV vaccine trial data. We also present initial results on the characterization of HLA-peptide interactions and their implications to the co-evolution of the immune system and pathogens it faces. We show how this tool can be used to discern highly immunogenic and highly non-immunogenic proteins encoded and expressed in an adenovirus vector used in a recent HIV vaccine trial. The disease focus of this proposal is HIV, and the tools will be developed and applied to HIV vaccine trial laboratory studies performed at the FHCRC HIV Vaccine Trial Network Laboratory Program. HIV remains one of the world's deadliest pandemics, with an estimated 2.5 million new infections last year and almost the same amount of AIDS deaths. Thus, with the great need for an HIV vaccine, the ongoing search for an effective vaccine is an intense focus of HIV research. By developing computational tools for predicting an individual's immune responses, we hope to gain insights into ways these responses can be altered, an advance which would help improve HIV vaccine design strategies as well as clinical trial design and analysis for HIV vaccines.

Public health relevance
Project Narrative HIV remains one of the world's deadliest pandemics, with an estimated 2.5 million new infections last year and almost the same amount of AIDS deaths. Thus, with the great need for an HIV vaccine, the ongoing search for an effective vaccine is an intense focus of HIV research. By developing computational tools for predicting an individual's immune responses, we hope to gain insights into ways these responses can be altered, an advance which would help improve HIV vaccine design strategies as well as clinical trial design and analysis for HIV vaccines. __SpecificAimsTextDelimiter__ Research Plan: Computational approaches to studying Immunodominance A SpecificAims T-cells detect the presence of pathogens within a cell by identifying short peptides which are recognized as foreign. Despite the large potential pool of pathogen peptides, only a small fraction of these epitopes are de- tected by CD8 T-cells during the course of an infection. This phenomenon, known as immunodominance, is a fundamental property of T-cell responses (Yewdell and Bennink, 1999). Immunodominance is a result of a large number of factors that govern antigen presentation and T-cell activation (Yewdell, 2006). Despite the complex nature of this phenomenon, it is relatively easy to experimentally measure its outcome in a given individual - any epitope that elicits a measurable immune response is an immunodominant one. In this proposal we outline a computational approach for studying immunodominance both in terms of anti- genic context and host genetics. The core of our approach involves the ability to predict HLA-peptide interactions, and we leverage previously developed tools for this analysis. The data we suggest to use is experimentally de- fined HIV-1 epitopes obtained in various clinical trials of the HIV Vaccine Trial Network. The disease focus of this proposal is HIV, and the tools will be developed and applied to HIV clinical trial data that is collected at by the HVTN. Specific Aim 1. To develop a computational method for predicting the immunodominant epitopes of a given subject exposed to an HIV vaccine. 1.a To conduct an in-depth evaluation of the predictive power of state-of-the-art MHC binding predic- tion methods for predicting immunological endpoints for subjects of several HVTN clinical trials including the Step trial. Rationale: The ability to predict immunological endpoints will be very valuable for several applications in human clinical trials of cell-mediated immunity based vaccines for the following applications: " Epitope mapping. " Efficient comparisons of immunogenicity endpoints among various candidate vaccines of Phase I/II trials. " Optimal sampling design and analysis of 'expensive' immunological endpoints that require intensive laboratory techniques. " Assessment of immunological correlates/surrogates of protection in Phase IIb/III efficacy trials. " 'Sieve analysis' of breakthrough HIV sequences in Phase IIb/III efficacy trials. 1.b Evaluate the feasibility of learning a ranking function over MHC-peptide pairs that would predict immunodominant responses for a subject. Rationale: The extensive epitope mapping done on subjects participating in HIV vaccine trials provides a unique opportunity to obtain large amounts of measured immunodominant epitopes. The availability of HLA typing for these subjects allows using in silico prediction methods for obtaining the set of sub- dominant epitopes of the subject, which in combination with the dominant ones can be used to learn a ranking function over a set of MHC-peptide pairs. Specific Aim 2. Explore the use of HLA targeting efficiency for identifying immunogenic targets for vaccine design, with a specific focus on various adenovirus vaccine vectors. Rationale: Using binding prediction tools and large amounts of available viral sequence data, we can now provide evidence that MHC alleles preferentially target conserved regions on both self and pathogenic proteins. HLA targeting efficiency measures the extent to which a specific MHC allele targets the conserved regions of a given pathogenic protein. This novel approach, which we have recently developed, allows the identification of pathogenic proteins that are very (in)efficiently targeted, which may help shape vaccine design strategies.